Organic Pseudometals to Sustain and Transform Small-Molecule Drug Synthesis

Project Summary
Transition metals are elements with unique reactivity that have changed the trajectory and success rate of
small-molecule drug discovery and manufacturing over the past decades. A quarter of the top 20 most used
reactions in medicinal chemistry are catalyzed by noble metals, and the majority of the top 200 selling small-
molecule drugs now contain either a biaryl or arylamine linkage (motifs easily accessible by Pd-catalyzed cross-
coupling). The dependence of medicine on transition metals is alarming, as most of the important metals are
toxic, expensive, environmentally damaging, and, most importantly, increasingly scarce, with several facing
effective extinction in the next century. Accordingly, there has been an urgent need to discover strategies to
force other more available and benign elements to substitute for transition metals in these essential chemical
processes. As an alternative, we ask whether, rather than using a single element, we might use entire organic
molecules (or fragments) as oversized surrogates for metals (“pseudometals”). First, we aim to show that
organic, metal-free catalysts can be capable of performing processes traditionally considered only possible with
transition metals, with special emphasis on oxidative addition and reductive elimination. We will then assemble
these elementary steps into catalytic mechanisms to achieve mimicry of cross-couplings, the most important
class of metal-catalyzed reactions in drug discovery. Second, we will extend the pseudometal concept from
mimicry to unprecedented reactivity, realizing metal-like transformations that are impossible with conventional,
periodic-table metals. These new cross-couplings will enable access to desirable chemical space for
accelerated drug discovery and more rapid construction of bioactive small-molecule agents. Finally, in a parallel
direction, we will investigate the combination of electrochemistry with rationally tailored redox-active organic
molecules to generate very weak X–H bonds akin to first-row metal hydrides, with the goal of functionalizing
ubiquitous alkenes and alkynes through a biologically-inspired hydrogen-atom transfer process. This research
goal will establish the potential of organic pseudometals to cover the whole range of transition-metal reactivity
and beyond, providing a roadmap for the design of efficient and enabling catalytic transformations to sustain
biomedical research in a transition-metal-free future.

Public health relevance
Project Narrative Over the past decades, transition metals have become indispensable for the discovery, optimization, and manufacturing of pharmaceuticals, but these elements are toxic, expensive, and limited in supply. To meet the urgent need for benign alternatives, we propose an unusual approach: the design of purely organic compounds (redox-active molecules) that can function as “pseudometals.” These catalysts will be used not only to mimic the essential reactivity metals for the synthesis of critical medicines, but they will also be rationally modified to access new transformations currently inaccessible to conventional transition metals.